Regulation of homotypic fusion by Chlamydia

PROJECT SUMMARY
The intracellular bacterium Chlamydia trachomatis is a major cause of sexually transmitted infections and
infectious blindness, with over 150 million cases worldwide. Yet, it is still considered a neglected disease
pathogen by the World Health Organization. Once inside the cell, Chlamydia replicates within a parasitic
compartment called an inclusion, the integrity of which is essential for Chlamydia survival. Inclusion
membranes are decorated with ~60 transmembrane Inc proteins that directly interact with host cell
components and play a critical role in sustaining Chlamydia’s life cycle. These inclusion proteins include IncA,
which is required for the homotypic fusion of chlamydial inclusions. This fusion event is important for
pathogenicity as patients infected with non-fusogenic C. trachomatis strains that express mutated forms of
IncA display fewer clinical symptoms than those infected with WT C. trachomatis. Yet, how Chlamydia controls
homotypic fusion is unknown. While the chlamydial protein IncA is involved, little is known about the molecular
mechanism regulating homotypic fusion. Here, we propose to test the hypothesis that the bacterial fusion
protein IncA uses a combination of intra- and extra-molecular regulatory mechanisms to control membrane
fusion and ensure the proper maturation of the inclusion. Our extensive expertise in membrane fusion and
Chlamydia pathogenesis places us in an ideal position to address this significant knowledge gap.
Unlike membrane fusion driven by eukaryotic cells and enveloped viruses, which are extensively studied,
membrane fusion driven by bacteria is poorly understood. This project will characterize a novel prokaryotic
fusion system, thus providing a roadmap to identify similar fusion systems in other bacteria. In parallel, data
gathered here will determine the extent to which this homotypic fusion event is essential for C. trachomatis
fitness, thus providing new information about disease progression.

Public health relevance
HEALTH RELEVANCE Chlamydia trachomatis is one of the most common causes of bacterial sexually transmitted infections and the leading cause of infectious blindness worldwide. Identifying how C. trachomatis promotes the fusion of its inclusions and characterizing the molecular regulation of the fusion machinery will provide invaluable insight into the mechanisms of disease progression. Furthermore, identifying the molecular machinery used by Chlamydia to promote membrane fusion will generate critical information for studying similar events with other intracellular human pathogens.